Exploring the function of bacterial condensates in adaptation and evolution

Project Summary
Physical organization of biomolecules within the cell is critical for controlling key life processes in health and
disease. It has recently been realized that in addition to membrane bound compartments such as the nucleus or
mitochondria, membraneless compartments may play a pivotal role in organizing biomolecules in the cell. Called
biomolecular condensates, these assemblies form by weak multivalent interactions and are known for their
spherical shapes and viscoelastic behavior. A biomolecular condensate can reversibly localize or delocalize
biomolecules in response to environmental cues. They can also interact with numerous biomolecules in a non-
stoichiometric manner. There is growing evidence suggesting that certain proteins in bacteria may function as
condensates. While they provide a means of compartmentalization for cells lacking traditional organelles, their
most impactful role could be as rapid response sensors. However, studying condensates in bacteria is
particularly challenging. Most evidence comes from laboratory-based reconstitution experiments that fail to
accurately replicate the true cellular environment, including context-dependent interactions. Due to the lack of
suitable tools, understanding the effects of condensates on phenotypes and inhibiting bacterial growth through
this novel mechanism have proven difficult. Current methods to assess condensate formation rely on
fluorescence microscopy, which is limited by the diffraction limit of light and cannot resolve structures smaller
than approximately 250 nm. Alternatively, proximity ligation-based assays followed by mass spectrometry are
often biased towards capturing strong interactions, thus neglecting dynamic interactions. In this proposal, we
aim to develop a novel approach that combines modular fluorophores and correlative super-resolution
microscopy to investigate the structure, dynamics, and interactome of condensates using genetically encoded
tags. Our goal is to apply this opto-proteomic toolbox to understand the role of biomolecular condensates in
various aspects of the bacterial cell cycle, surface colonization, and evolution within both free and host
environments. This approach will be readily applicable for the study of condensates in other bacteria and beyond,
while shedding light on the nanoscale mechanisms that impact macroscopic phenotypes.

Public health relevance
Project Narrative Recently, it has been realized that bacterial sensing and adaptation to environmental fluctuations is promoted by condensates, which are structures that concentrate proteins and nucleic acids. However, due to their extremely small size and dynamic interactions, current methods are unable to provide insights into the exact workings of condensates in bacteria. This proposal aims to observe the structure, dynamics, and interactions of bacterial condensates at utmost resolution, ultimately shedding light on their role in the adaptation of both free-living and host-associated bacteria.